Cardioprotective Therapy for Doxorubicin Using iPSC Microtissue and CRISPR Screening

PROJECT SUMMARY
In tandem with recent improvements in anti-cancer treatment efficacy, cancer treatment-related cardiotoxicity
has become a serious clinical problem. Doxorubicin-induced cardiotoxicity (DIC) is one of the most common
chemotherapy-related cardiotoxicities. Here, combining human induced pluripotent stem cells (iPSCs) with
large-scale CRISPR screening, nanotechnology, and engineered 3D cardiac microtissue technology, we will
develop a pipeline which enables us to identify therapeutic targets and potential chemical compounds that
protect cardiomyocytes from DIC. First, we will perform genome-wide perturbation screening in doxorubicin
resistance using CRISPR technology. It will enable us to identify druggable genes that are causative for DIC or
essential for resistance in DIC. Second, we will perform high-throughput screening of chemical compounds
using nanoparticles. It will enable us to identify cardioprotective chemicals and compile a Cardioprotective
Drug Repurposing Library. Third, we will develop a 3D cardiac microtissue platform that can detect
cardioprotective effects of the candidate therapies. The 3D cardiac microtissue will consist of iPSC-derived
cardiomyocytes, endothelial cells, and fibroblasts, reflective of complex cell-cell interaction and
microenvironment. The goal of this proposal is identify cardioprotective therapy for DIC and to develop
platforms that are expandable to other cancer treatment-related cardiotoxicities.

Public health relevance
PROJECT NARRATIVES Although recent developments in anti-cancer treatments have improved cancer patients’ outcome, a significant number of cancer survivors are now suffering from heart failure that is caused by cancer treatments as adverse side effects. Doxorubicin, one of the most common chemotherapy drugs, is well known for its cardiotoxicity, but currently it is still difficult to predict who will develop doxorubicin-induced cardiotoxicity (DIC) and to prevent it. Here, we will make a platform to develop “cardioprotective” therapy against DIC using 3D cardiac microtissues as a surrogate to mimic patients’ hearts, which will significantly improve the risk assessment and risk reduction of DIC, and furthermore can be applied to other cancer treatment-related cardiotoxicities.